Edema Calcified Foci/Seizures-Inactive Cysticercosis

Seizures are the most common clinical manifestation of cerebral cysticercosis and occur in the presence of viable, dying, and calcified or non-calcified dead cysts. How calcified cysts provoke seizures is not known but recent observations demonstrated edema around some calcified lesions at the time of seizure activity and disappearance during periods when seizures were not occurring. Edema associated with foci in idiopathic epilepsy is highly unusual so that this observation suggests that the mechanism(s) associated with calcified cysts is unique. Documenting and understanding this phenomenon is important for a number of reasons. First, although by definition these lesions are inactive, e.g., not living larvae and do not require anti-parasitic treatment, they are frequently mistaken for active lesions and patients undergo unnecessary treatment. Second, a likely reason for perilesional edema is intermittent antigen release and subsequent host immune response resulting in inflammation and edema. If proven, then the treatment for this would not only involve suppression of seizure activity with anti- seizure medication, but also the use of anti-inflammatory medications such as corticosteroids. A study was initiated in Peru to determine 1) the frequency of perilesional edema around calcifications 2) the frequency of associated symptoms 3) what lesions and patients have a propensity to undergo this phenomenon 4) the natural history of perilesional edema and 5) whether treatment of patients with perilesional edema with corticosteroids results in enhanced regression of edema and clinical benefit. During accrual of patients to perform the above study, a baseline MRI was obtained in patients with or without current symptoms. A prospective study of patients with a history of seizures and only calcific neurocysticercosis is on going in Peru and accrual of patients is continuing. Preliminary analysis showed that approximately 20.5% of prospectively followed patients with only calcifications and a history of seizures have had a seizure after about 2 years of follow-up. 38.9 % of those with seizure have had perilesional edema. This suggests that seizures are relatively common in this population and perilesional edema is caused or associated with over a third of the episodes. The treatment arm of the study was stopped because there was no statistical way to show benefit of corticosteroids.